Differentiation of Osteogenic Sarcoma by MYC

DESCRIPTION (provided by applicant): The MYC oncogene is a transcription factor whose overexpression is thought to induce tumorigenesis by causing inappropriate gene expression that results in autonomous cellular proliferation and a block in cellular differentiation. Recently, we have found that even the brief inactivation of the MYC oncogene can result in the sustained loss of a neoplastic phenotype. We demonstrated that upon MYC inactivation immature osteogenic sarcoma cells differentiated into mature osteocytes and formed bone. Surprisingly, MYC reactivation failed to restore a neoplastic phenotype and instead induced the now differentiated tumor cells to undergo apoptosis. Our results suggest to us the interesting possibility that MYC inactivation causes the loss of a neoplastic phenotype by inducing tumors to differentiate. In this new epigenetic context, the ability of the MYC oncogene to induce the expression of genes responsible for sustaining cellular proliferation and hence tumorigenesis has been revoked and now instead apoptosis occurs. We hypothesize, that upon differentiation the tumor cells undergo chromatin remodeling and this new epigenetic program prevents MYC from inducing the transcription of genes required to induce or sustain tumorigenesis. Instead, MYC activation induces apoptosis. To examine for this possibility, we propose: to determine the duration of MYC inactivation required to result in sustained loss of a neoplastic phenotype by time lapsed video microscopy; to determine if the ability of MYC to activate the transcription of different gene targets changes upon differentiation of tumor cells by examining the expression of specific target genes by RT-PCR and global changes in gene expression by cDNA microarrays and by measuring the accessibility of specific target gene loci to MYC binding by chromatin immunoprecipitation and histone acetylation; and to determine if the ability of MYC to induce apoptosis changes upon the differentiation of tumor cells by examining the change in expression patterns of both pro- and anti-apoptotic gene products and by directly determining the effects of the inhibition of apoptotic pathways. The results of our experiments may have important implications for how the state of differentiation of a cell influences the ability of MYC to induce gene expression and thereby initiate and sustain tumorigenesis.